COMPARISON OF WORKFLOW MANAGEMENT SYSTEMS FOR FMRI

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this project is to provide a hands-on comparison of different workflow management software in order to determine the most flexible, robust software available for fMRI data analysis.